ORAL FRUCTOSE SUPPLEMENT FOR MANAGEMENT OF GESTATIONAL DIABETES

This study is designed to look at the effects of fructose in mixed meals upon the substrate and hormonal responses of normal and gestationally diabetic pregnant women. In non-pregnant diabetic subjects, supplementation and/or substitution of carbohydrate with fructose appears to improve the metabolic regulation.